A Technology-enhanced and Multilevel Approach to Promote Cervical Cancer Prevention Among Women Living with HIV

incidence and longer persistence of high-risk
PROJECT SUMMARY/ABSTRACT
(WLH) bear a disproportionate risk of invasive cervical cancer (CC) due to greater
human papillomavirus (HPV) infection. Despite the availability of effective
Women living with diagnosed HIV
CC screening methods, there is low CC screening uptake among WLH. Reasons for suboptimal CC screening uptake
among WLH are complex and multifactorial. Multilevel interventions that simultaneously address modifiable barriers to
screening at different levels of influences are therefore needed to effectively reduce CC disparities among WLH. To
achieve the World Health Organization’s recommended global target to eliminate CC by 2030, accelerated progress in
complex health problems may also likely come from the integration of social innovations and technological advances.
The overall objective of this proposed K01 project is to conduct formative research and pilot test the provider-level
and patient-level components of the My Self-Sampling for HPV Awareness, Results, and Empowerment (MySHARE+)
intervention. MySHARE+ aims to harness the power of technology and apply a multilevel approach to promote the
adoption of CC screening (HPV self-sampling; Pap triage adherence) among under/never-screened WLH, a vulnerable
population. The specific aims are to: 1) identify facilitators and barriers to implementing a healthcare provider prompt in a
primary care setting and 2) conduct a pilot RCT to examine the feasibility, acceptability, and preliminary efficacy of a
mHealth educational intervention in promoting CC awareness and HPV self-sampling among WLH. These aims align
with the NCI’s mission to advance scientific knowledge to reduce the unequal burden of cancer and purposely addresses
their areas of research emphasis in biobehavioral research and in improving health disparities by targeting multiple levels
of influences. Study findings will generate implementation feasibility and acceptability data from the provider and patient
perspectives, and inform a subsequent R01 that will test the impact of the MySHARE+ intervention in a large cluster
randomized trial where the independent and overlapping effects of the different components can be evaluated.
Strongly supported by mentors and advisors who are leading experts in the methodological and content areas specific
to her long-term goals, Dr. Le’s proposed K01 includes a comprehensive training plan that will help her acquire new
knowledge and advanced skills in: 1) quasi-experimental studies and cluster-RCTs using multilevel approaches, 2) digital
health/technology-based interventions to promote patient-centered care, and 3) implementation science methodologies and
frameworks. Over the 5-year award period, she will participate in mentored research, one-on-one and advisory/team
meetings, didactic instruction, directed readings, training seminars, and scientific meetings. The aforesaid research and
training activities will undoubtedly help Dr. Le achieve her overall academic career objective of leveraging academic-
community-government partnerships to successfully execute and sustain community-driven and clinically-embedded
intervention research supported by health information technology and the remote delivery of primary health care services
to enhance patient-centered care. GW is well poised to support Dr. Le in undertaking these research endeavors, especially
due to the expertise on faculty, its location and reputation in the city, and the institution’s high quality research setting.

Public health relevance
PROJECT NARRATIVE Women living with HIV (WLH) have a greater risk of developing invasive cervical cancer due to greater incidence and longer persistence of high-risk human papillomavirus infection. The primary objectives of this NCI K01 proposal are to: (1) conduct formative research and pilot test the provider-level and patient-level components of the My Self-Sampling for HPV Awareness, Results, and Empowerment (MySHARE+) intervention to increase cervical cancer screening (HPV self- collection; Pap triage adherence) among under/never-screened WLH and (2) provide Dr. Le with didactic training, directed mentorship, and experiential learning opportunities to develop cancer prevention and control research methods skills and content expertise in quasi-experimental studies and cluster-RCTs using multilevel approaches, digital health/technology- based interventions to promote patient-centered care, and implementation science methodologies and frameworks. This career development award will undoubtedly enable the candidate to comprehensively and systematically expand her multidisciplinary research training and effectively facilitate her successful progression towards independence as a behavioral health researcher with an extramurally-funded program in evidence-based bio-behavioral interventions to reduce cancer health disparities.